Risk prediction and longitudinal assessment of cardiotoxicity and functional capacity trajectory in NSCLC patients

Project Summary/Abstract
Non-small cell lung cancer (NSCLC) is the most prevalent form of lung cancer, accounting for approximately
85% of all lung cancers, which is one of the deadliest types of cancers. Standard NSCLC treatments include
surgery, immunotherapy, chemotherapy, and radiation therapy. Radiation therapy can be delivered by either
photons or protons; however, both types of radiation therapy to the chest can result in cardiac injury. To date,
no available clinical tool exists to guide physicians in choosing the best type of radiation therapy according to an
individual’s risk for radiation-mediated cardiac injury. To plan radiation therapy, normal tissue complication
probability (NTCP) models are commonly used and take into consideration differences in geometric shape or
volumes between tumor and non-tumor tissue, as well as tissue dose constraints. However, these patient
population-reliant models are based only on photon radiation therapy data (not proton), do not consider the
differences in radiation vulnerability of organ substructures, and do not consider the individual NSCLC patient’s
risk for a specific toxicity (e.g., cardiac toxicity). Hence, this proposal tests the hypothesis that chemoradiation-
related cardiac toxicity can be minimized by dose optimization and individual pre-existing cardiovascular risk-
stratification for choosing appropriate radiation modality. Pre-existing cardiovascular risk factors, such as
individual genetic predisposition, cardiac injury blood biomarkers, and extent of vascular calcification will be
correlated with chemoradiation-associated cardiac toxicity and overall survival (OS) in Aim 1. Data on pre-
existing cardiovascular risk factors will be retrospectively collected from two prospective, randomized
comparisons of photons vs. protons and from a registry trial, which included proton-treated patients not enrolled
into the randomized trial. Associations between pre-existing cardiovascular events and radiation therapy-
mediated cardiac events as well as OS will be used as parameters to generate a one-of-a-kind NTCP model
(Aim 2). In Aim 3, a prospective cohort registration trial will be developed to longitudinally assess cardiac function,
cardiac fitness, and model implementation. During model implementation, two maximally optimized radiation
therapy plans for each enrolled patient will be developed: 1) using standard population-based dose constraints;
and 2) using personalized dose constraints based on individual risk. A predefined NTCP goal will be set to
evaluate both plans. If the personalized plan improves the NTCP goal by 15%, the patient will be treated using
the personalized plan. The model performance will be continuously assessed and improved using the data
accumulated from the trial. The long-term objectives of this proposed project are to minimize cardiovascular
injury while optimizing NSCLC patient outcomes, based on individual patient risk to cardiac injury after concurrent
chemoradiation therapy by multivariable model selection of radiation therapy modality and technique. Preventing
cardiovascular injury in cancer patients so that individuals can live longer, and more fulfilling lives is in direct
alignment with the mission of both the National Cancer Institute and the National Heart, Lung, and Blood Institute.

Public health relevance
Project Narrative Radiation therapy, along with surgery, chemotherapy, and immunotherapy, is the gold standard for treating lung cancer. Unfortunately, during radiation treatment of the lungs, the heart can become damaged. In order to decrease the risk of heart damage, this proposed project will focus on establishing a clinical practice guidance model, based on pre-existing cardiovascular risk factors, to help clinicians choose the best type of radiation therapy and the optimal radiation dose for each individual lung cancer patient.